Two-Spirit Films in Indigenous Cancer Health

Project Summary/Abstract
Cancer and health-related community outreach and education efforts progressively rely on digital
media to reach and inform important target audiences. To address cancer disparities among
Indigenous sexual and gender minorities (SGM), the aim of this proposed project is to adapt the
existing framework from the previous MICEO grant (P30CA016056-46S2) and update cancer
health messaging with Indigenous SGM specific language, inclusive cancer health education, and
we will engage, and package cancer health messaging directly with and for Two-Spirit and
Indigenous LGBTQ+ communities as it relates to colorectal and liver cancers. The project titled
Films for Indigenous Cancer Health: Engaging Two-Spirit & Indigenous LGBTQ+ (lesbian,
gay, bisexual, transgender, queer, plus other identities) Communities (FICH: 2SLGBTQ+
Communities) will adapt cancer health messaging through short films with Two-Spirit and
Indigenous LGBTQ+ social media influencers and icons for use in community-based health
centers and is guided by the Transportation-Imagery Model of Narrative Communication. The
project will adapt practices from the previous MICEO project to integrate community-based
practice, prevention messaging, cancer screening information to increase cancer-based
knowledge (specific to colorectal and liver cancers), intent, and behaviors among Indigenous
SGM communities. This will be accomplished by collaborative efforts from an NCI-designated
cancer center’s Department of Indigenous Cancer Health, Community Outreach and
Engagement, Health Communications Resources and Medical Illustrators alongside Indigenous
media networks and community-based film companies. Objectives include film creation, hosting
screenings at Two-Spirit and Indigenous LGBTQ+ gatherings (powwows, Two-Spirit society
events, etc.), panel discussions with film creators and Indigenous influencers/icons, and the
embedment of films into the cancer center’s Indigenous outreach, engagement, and prevention
digital repository. Evaluative efforts include co-produced films guided by an intertribal community
advisory board with Indigenous SGM representation, pre-post surveys on knowledge, attitude,
cancer prevention, and screening behaviors. The long-term goal is the continuance of community
outreach for Indigenous communities, Indigenous urban centers with sustainable integration into
Indigenous and SGM health service delivery systems. Overall, results are expected to increase
community-based collaborative efforts through health messaging and serve as a model for
Indigenous SGM inclusion in cancer health education practices.

Public health relevance
Project Narrative Cancer health education can utilize digital media to inform. To address cancer disparities among Indigenous sexual and gender minority populations, health film approaches will be adapted to co- create between a cancer center health communications team, medical illustrators, and Two-Spirit and Indigenous LGBTQ+ influencers to increase cancer-based awareness.